Laser Scanning Confocal Microscope

A. Project Summary
We are requesting funds to purchase a new Nikon AXR laser scanning confocal that will be housed within
the BioFrontiers Institute’s Advanced Light Microscopy Core (ALMC) at the University of Colorado Boulder. The
new microscope will replace our Nikon A1R laser scanning confocal that is approaching End-of-Life (April 2023)
and is unable to meet the future needs of our Major and Minor Users. The Nikon AXR will allow our 14 Major
and Minor Users that represent 21 different NIH-funded awards (16 R01, 2 R35, one each R03, R21 and RF1)
to continue their research while pursuing new avenues of investigation in search of human health solutions
utilizing live 3D cell-laden hydrogels and organoids as models.
The Nikon AXR offers multiple advantages compared to currently available technologies. Our current Nikon
A1R limits our Users with its a) small field of view (4096x4096 with the galvanometer, 512x512 with the resonant
scanner) which slows image acquisition times, b) reduced piezo Z range (100 µm), and c) the lack of high-
resolution objectives for long-term high-throughput live cell imaging due to immersion evaporation. Compared to
the A1R, the Nikon AXR has a larger field of view for Nyquist sampling (up to 16x larger with the resonant
scanner, depending on the objective), a faster resonant scanner for imaging rapid kinetics, the availability of
larger piezo Z inserts allowing for fast, repeatable Z stacks (up to 600 µm), along with the Okolab environmental
chamber, a water immersion dispenser that enables long-term live cell imaging and the screening of slides and
multiwell plates using high-resolution water immersion objectives, and new detectors with improved sensitivity
with two GaAsP and two multiAlkali detectors.
Since it was purchased in 2012, the Nikon A1R enabled our NIH-funded Users to achieve scientific success
resulting in 32 publications and nearly 1400 citations. However, it cannot be further upgraded to meet the future
needs of the Major and Minor Users. Acquiring a Nikon AXR will enable our Users to advance their research
projects beyond what is currently capable by growing to meet the future needs of their studies, including the
ability to image entire multiwell plates over time using water immersion objectives, high-resolution repeatable Z
stacks of large organoids (up to 600 µm in Z), and rapid, multidimensional imaging of diffusing objects.
The Nikon A1R has been an essential resource for the BioFrontiers Institute and the University of Colorado
Boulder. As the first instrument purchased for the ALMC, it has been used to great success, especially in terms
of its applicability towards the multidimensional imaging of live samples to help unravel the fundamentals of
biology to enhance human health. Such a tool is critical to our current and future success of biological
investigation applied towards innovating human health solutions at our institution. Without the new Nikon AXR,
numerous NIH investigators will be negatively impacted, and their research adversely impeded.

Public health relevance
B. Project Narrative A laser scanning confocal microscope is a critical tool in the arsenal of our NIH-funded investigators investigating the fundamentals of biology in pursuit of innovating human health solutions. We are requesting funds to purchase a new Nikon AXR laser scanning confocal microscope to replace our aging Nikon A1R that, while currently functional, is approaching its end-of-life and at risk of detrimental failure, negatively impacting current and future projects of our Users. Without this new instrument, our investigators will be restricted in their capabilities, hampering potential discoveries, and impeding scientific advancement.